Learning from Remission and Relapse in SLE

Abstract – Overview
This program project is an exploration of patients with Systemic Lupus Erythematosus who are in long term
clinical remission on no corticosteroid or immunosuppressive medication.
We will study blood immune cells at the single cell level exploring distribution of cellular subsets and
transcriptional, epigenetic and proteomic profiles, as well as the repertoire of naive and memory B cells
reactive with nuclear antigens.
We will explore brain function in these patients to determine if there is ongoing inflammation in the central
nervous system in some patients despite a lack of inflammation in the periphery.
Given the now recognized interplay of the immune system and the brain, we will seek correlations between
immune cell profile and brain function.
As approximately 25% of patients in remission can be expected to relapse over 5 years, we will seek predictors
of relapse.
These studies should teach us about patient heterogeneity, novel states of immune or brain homeostasis, and
predictors of sustained remission or flare.

Public health relevance
Overview Narrative This is study of blood immune cells and brain function in patients with Systemic Lupus Erythematosus in long term clinical remission on no corticosteroids or immunosuppressive medication. We believe that studying this population will provide insights into patient heterogeneity, new patterns of immune homeostasis to inform therapeutic strategies and the state of central nervous system inflammation in those with no detectable peripheral organ inflammation. As 25% of patients will flare over 5 years, we will look for predictors of relapse.